The 10,000 Families Cohort: a new study to understand the environmental causes of cancer

Abstract
The 10,000 Families Study (10KFS) will be a new, family-based cohort study in Minnesota, the ‘Land of 10,000
Lakes’. Due to our high incidence rates of hematologic malignancy (leukemia, lymphoma, and myelodysplastic
syndromes), we will focus our proposal on environmental exposures of concern that are possible hematologic
carcinogens with limited evidence in humans as defined by the International Agency for Research on Cancer
(IARC). This includes glyphosate, poly- and perfluoroalkyl substances (PFAS), and radon, all of which have
well-described geographic variation in prevalence in the state of Minnesota. During the UG3 phase, we will
evaluate innovative exposure assessment methodologies and recruit diverse participants into the 10KFS
cohort. Exposure assessment will include residential history, ambient measures in air and water at current
residence, as well as individual-level exposure assessed with silicone wearable bracelets, serum, hair, and
urine. Participants will be recruited from targeted counties that maximize the exposure distribution to our three
carcinogens of interest and include under-represented populations from rural and immigrant communities. We
will measure clonal hematopoiesis of indeterminate potential (CHIP), a precursor to heme malignancy, and
perturbations in immunity and epigenetics as our primary cancer-related outcomes in the UH3 phase. Our
target is to recruit 8,750 participants from 4,000 households to participate using recruitment strategies that
have been developed and pilot tested. Our central hypothesis is that PFAS, glyphosate and radon contribute to
increased hematologic malignancy specifically, and cancer incidence broadly, in Minnesota. Cancer incidence
will be determined via annual record linkage with the Minnesota Cancer Reporting System (MCRS) and the
Virtual Pooled Registry Cancer Linkage System. The scientific aims in the UG3 phase will be to: 1) evaluate
innovative exposure assessment methods for PFAS and glyphosate that can be easily implemented in a large
scale study and 2) describe the exposure burden in under-represented immigrant populations. We will
complete recruitment of the study population in the UH3 phase where the specific aims are to: 1) determine
whether levels of radon, glyphosate, and PFAS are associated with increased prevalence of CHIP and 2)
utilize epigenomics to test the hypotheses that radon, glyphosate and PFAS exposure are associated with
immune dysregulation and epigenetic signatures. Our community engagement will be conducted in partnership
with the non-profit research institute Hispanic Advocacy and Community Empowerment Through Research
(HACER), the Minnesota Freemasons and Order of the Eastern Star and community educators from the
Extension Center for Family Development. The results of this study will provide needed data to inform whether
these agents are hematologic carcinogens, it will address documented disparities in exposure that occur within
our state and provide a mechanism for community outreach and education concerning these exposures and
any potential cancer link.

Public health relevance
Project Narrative Environmental exposures with carcinogenic potential are a concern to individuals living in Minnesota, including poly- and perfluoroalkyl substances (PFAS), glyphosate (RoundUp), and radon. The impact of these exposures may be especially relevant for populations that have been typically under-represented in existing cohort studies such as individuals living in rural areas, racial/ethnic minorities, and immigrants. We are proposing to launch a new cohort study to investigate these relevant exposures and risk of malignancy.